A Randomized Clinical Trial of a Peer Education Intervention to Promote Social Diffusion of Overdose Prevention and Drug Use Cessation in High Burden Communities

Abstract:
The US opioid epidemic has significantly impacted public health, with high levels of opiate dependence and a
surge in overdoses. The increasing prevalence of fentanyl and xylazine in the drug supply underscores the
importance of novel approaches. Additionally, times of withdrawal have been found to increase overdose risk
behaviors, highlighting a need to target this period. Particularly in the context of xylazine, as naloxone does not
reverse the effect of xylazine-induced respiratory depression, enrollment and retention in medications for
opioid use disorder (MOUD) is vital to reduce drug overdoses. In our prior work, we have shown that PWUO
can be trained as peer educators (PEs) for overdose prevention, but we have not integrated withdrawal
management or a social network approach to MOUD engagement. This five year proposal seeks to develop,
implement, and rigorously evaluate a novel PE intervention designed to prevent overdoses and promote
MOUD and drug use cessation among a population of PWUO disproportionally impacted by overdose (Funding
Option B). The intervention has three novel components: (a) social network diffusion of overdose prevention
and MOUD promotion, (b) strategies to address high-risk withdrawal periods, and (c) Certified Peer Recovery
Specialist (CPRS)/ Contingency Management (CM) for MOUD engagement. Using an RCT study design, 300
index PWUO will be recruited along with 300 of their network members who use opioids. The indexes will be
randomly assigned to the (1) standard of care (SOC) or (2) an experimental peer education condition (PEC).
The proposed design allows for the examination of the effectiveness of the intervention on indexes and
diffusion of behavior change to network members. The RE-AIM framework will guide the collection of
qualitative interview data to identify barriers and facilitators to intervention implementation. Assessments will
occur every 3 months for one year.
1. Development and Pilot Testing: Design and pilot test intervention components that diffuse overdose
prevention behaviors and MOUD within social networks, promote overdose prevention during
withdrawal, and enhance MOUD engagement through CPRS/CM.
2. Implementation of RCT: Evaluate the intervention in a 1:1 RCT, testing an intervention that includes
(a) social network diffusion of overdose prevention and MOUD promotion, (b) strategies to address
high-risk withdrawal periods, and (c) CPRS/CM for MOUD engagement (N=600; 300 index participants,
300 network members).
3. Evaluation of Outcomes: Assess changes in nonfatal overdose, drug use cessation, MOUD
engagement, and overdose prevention behaviors among index participants, as well as the diffusion of
these behaviors to their social network members.

Public health relevance
PROJECT NARRATIVE Previous interventions have not focused on social network overdose prevention and medications for opioid use disorder (MOUD) engagement approaches for people who use opioids (PWUO). However, there is a critical need to maximize the uptake of overdose prevention practices, including MOUD, especially in the context of potent opioids and adulterants such as xylazine. Developing and evaluating programs to train PWUO to diffuse overdose prevention strategies and MOUD to their network members can reduce community- level drug overdoses and promote drug use cessation among populations disproportionately impacted.